Primary Prevention of Intimate Partner Violence

PROJECT SUMMARY
Intimate partner violence (IPV) is experienced by one-fourth of women in India and associated with poor mental,
physical, sexual and reproductive health, leading many experts including the World Health Organization to call
for the urgent development of effective primary IPV prevention. We previously developed an evidence-based,
theory-driven, dyadic intervention, Ghya Bharaari Ekatra (GBE, “Take a Flight Together,” NIH/FIC K01
TW009664) for the primary prevention of IPV among newly-married couples residing in slums in India. GBE is
delivered over six weekly sessions by a team of lay peer educators to groups of five couples, and makes use of
engaging culturally-tailored delivery methods to challenge norms and build knowledge and skills to address six
key IPV determinants: limited relationship quality time, poor self-esteem, resilience, communication and conflict
management, sexual communication and sexual/reproductive health knowledge, and conservative IPV norms
and definitions. In a pilot study of 40 couples married < 1 year, we found that GBE demonstrated high acceptance
(with 85% of participants retained across all 6 sessions), feasibility, safety (no reported adverse events), and
preliminary efficacy in preventing IPV and improving mental health in the female partner. We now seek to quantify
GBE’s impact on IPV and downstream outcomes, mental health and reproductive autonomy, examine its
mechanism of action, contexts in which it may need modification, and factors associated with its future successful
adoption and implementation. We hypothesize that (1) GBE prevents IPV experience and enhances reproductive
autonomy among women,(2) GBE improves mental health among both dyadic members, and (3) GBE’s effects
are mediated by the IPV determinants it was designed to address. Our team, with 15 years of IPV research
experience in India, proposes a cluster randomized trial of 850 newly married dyads (500 to GBE and 350
controls) in Maharashtra, India to execute the following aims: 1) to quantify the impact of the GBE intervention
compared to the ethical standard of care (information on IPV and mental and reproductive/sexual health
resources) in preventing IPV experience (primary outcome), enhancing reproductive autonomy among newly
married women (secondary outcome) and mental health among the both members of the dyad (secondary
outcome) at 12 months; 2) to conduct mediation and moderation analyses for the efficacy of the GBE
intervention; and 3) to identify barriers, facilitators, and strategies for future, successful adoption and
implementation of GBE through exit interviews with GBE participants and qualitative interviews, guided by
Consolidated Framework for Implementation Research, with interventionists, adopters, and other stakeholders
who have influence over implementation outcomes. Study findings will provide the information necessary to
facilitate scale-up of GBE across India and similar resource-limited, high-burden settings globally upon study
completion.

Public health relevance
PROJECT NARRATIVE Intimate partner violence is experienced by one-fourth of women globally and linked to poor mental, physical, sexual, and reproductive health, thus underscoring the need for innovative, effective strategies to prevent intimate partner violence. The proposed study examines the impact of a couples-based intervention, “Ghya Bharaari Ekatra,” in preventing intimate partner violence and enhancing reproductive autonomy and mental health among newly married couples in India. The study will provide critical insight on the efficacy of the intervention, its mechanism of effect, contexts that may modify its effects, and the barriers, facilitators, and strategies for its successful future adoption and implementation, thereby enabling rapid scale-up of the intervention across India and similar resource-limited, high-burden settings globally upon study completion.